Structure-guided and high-throughput engineering of genetically encoded sensors for reactive oxygen species

PROJECT SUMMARY / ABSTRACT
Elevated levels of reactive oxygen species (ROS) are linked to severe pathological conditions causing
cardiomyopathies and neurodegeneration. Today we can utilize fluorescent probes to detect dynamic changes
in ROS levels in cell physiology and pathophysiology. However, many ROS sensors’ capabilities are still limited
by small signal amplitudes, slow kinetics, low sensitivity, in vivo incompatibility, and cellular and subcellular
targeting restraints. Thus, monitoring ROS in real-time in cells and behaving animals is still very restricted. Our
central goal in this proposal is to resolve current limitations in ROS protein sensors. We will combine structured-
guided protein design and functional high-throughput screening of large variant libraries in an innovative
approach to engineer novel ROS sensors. We expect that significantly increasing signal amplitudes, kinetics
and sensitivity, will enable us to monitor ROS signaling for the first time in the brain of behaving mice.
Furthermore, we will validate sensors in models for neurodegeneration and cardiomyopathies with subcellular
precision in human stem-cell-derived cell lines. In the first aim, we will use protein structures to guide targeted
mutations to increase ROS sensitivity and allosteric coupling between the sensor and reporter domain. In the
second aim, we will use a novel engineering platform for fluorescent sensors to screen large libraries of
randomized variants. The fast, iterative process has the potential to significantly accelerate the optimization of
sensor frameworks established in Aim 1. In the third aim, we will validate our sensors in several realistic use
scenarios to receive immediate feedback for further refinement of sensor function. This includes monitoring ROS
as second messengers in behaving mice and monitoring oxidative stress as an indicator for pathophysiology in
stem-cell-derived neurons and cardiomyocytes. This proposal is significant because oxidative stress is common
and can affect every organ and cell type resulting in many severe diseases. Recent progress in fluorescent
microscopy allows us to utilize specific probes to monitor physiological processes with increasing precision. Our
project is innovative because the proposed approach will provide the fastest throughput for designing highly
efficient ROS sensor proteins. Furthermore, the improved sensors will be able to causally link disease
phenotypes to acute and chronic stressors of oxidative stress with significantly increased temporal and spatial
resolution.
Here we request the purchase of a microfluidic valve control from CellSorter Company for Innovations,
Hungary to more efficiently pick cells from PDMS microarrays during high-throughput screening in Aim 2.
Integration of the instrument into our existing pipeline will further increase throughput, and the success rate to
retrieve highly optimized ROS sensors while also reducing time and resource commitments.

Public health relevance
PROJECT NARRATIVE Genetically-encoded, fluorescent sensors for reactive oxygen species (ROS) provide tremendous potential for studying oxidative stress and cell-signaling in real-time but their low fidelity does currently not allow for large scale in vivo studies. We aim to significantly accelerate the engineering of ROS sensor proteins by combining structure-guided design with a novel high-throughput platform enabling the functional testing of large variant libraries at high-speed. The fast engineering of fully applicable ROS sensors will allow biomedical researchers to precisely detect the timing and location of oxidative stress in correlation to environmental stress and intracellular signaling and hence, could guide future research on disease mechanisms, facilitate drug screening, and help to identify novel therapeutic approaches.